Gene regulatory network of memory B cell and long-lived plasma cell differentiation

Abstract
The generation of long-lasting humoral immunity is the purpose of almost all vaccines. Long-lasting humoral
immunity is mediated through antibodies produced by plasma cells (PCs) and memory B cells (MBCs). Despite
the outstanding success of vaccinations overall, many clinical and experimental vaccines fail to induce long-
lasting humoral immunity. One key example is the influenza vaccine, which requires administration every year.
Upon encountering a foreign antigen, antigen-specific B cells proliferate and differentiate into the germinal center
(GC) B cells and subsequently generate PCs and MBCs. B cell receptor and CD40 receptor signaling result in
the activation of NFkB in GC B cells. It is well established that transcription factors NFkB cRel and RelA are
critical for physiological B cell responses and that their misregulation leads to B cell-mediated diseases. cRel
and RelA are essential for generating GC B cells and PCs. The activation of cRel and RelA depends on the
degradation of NFkB inhibitors, IkBs. IkBa and IkBe have different binding preferences to cRel and RelA. IkBa
binds to RelA-containing dimer (RelA:p50) with a higher affinity than cRel-containing dimer (cRel:p50), whereas
IkBe binds to cRel:p50 with a higher affinity than RelA:p50. The network of IkBa, IkBe, cRel, and RelA is defined
here as the NFkB signaling network. The role of the NFkB signaling network in regulating affinity maturation and
generating PCs versus MBCs is unknown. In this project, we will define the role of the NFkB signaling network
in regulating affinity maturation and in the generation of PCs versus MBCs. The objective of Aim 1 is to define
how IkBa and IkBe regulate affinity maturation and the generation of PCs and MBCs. The objective of Aim 2 is
to identify how cell surface receptors regulate the abundance of IkBa and IkBe and thus control cRel and RelA
activation in GC B cells. The objective of Aim 3 is to determine whether the vaccine-induced response of IkBa-
deficient and IkBe-deficient mice can enhance humoral immunity against influenza infection.
The proposed research is innovative because it defines the discrete role of IkBa and IkBe in regulating the fate
of GC B cells. This work uses newly generated cRel and RelA fluorescence reporter mice and IkBe and IkBa
knock-out mice. The proposed research is expected to define the mechanism that allows the NFkB signaling
network to controll different gene regulatory programs within phenotypically-identical GC B cells to regulate
affinity maturation, as well as the generation of PCs and MBCs. The study will reveal new insights into the
generation of long-lived humoral immunity and improve immunity against influenza.

Public health relevance
Project Narrative The proposed research is relevant to public health because many clinical and experimental vaccines fail to generate long-lasting humoral immunity, which is a key to preventing infection in the long-term. The proposed study’s expected result of in-depth understanding of the transcriptional regulation of generating long-lasting humoral immunity that will be instrumental in identifying targets for pharmacological intervention and designing an immunomodulator/vaccine adjuvant that can enhance the duration of long-lasting humoral immunity upon vaccination. Thus, the proposed research is relevant to the NIH’s mission to develop fundamental knowledge that will help to reduce the burdens of human disease and disability.